Acceptance and Commitment Therapy for HIV+ hazardous drinkers: A randomized clinical trial

Project Summary/Abstract
Alcohol consumption at hazardous levels is associated with negative consequences at nearly every step of the
HIV care continuum. It is a critical factor in HIV treatment that significantly contributes to poor treatment-related
outcomes. Randomized clinical trials (RCTs) of alcohol interventions for people with HIV (PWH) have had
limited success, perhaps due to an increasingly recognized syndemic of co-occurring hazardous alcohol use
and other mental health-related problems among PWH. Up to 63% of PWH meet criteria for both a substance
use disorder and another psychiatric disorder—necessitating a shift in the literature towards transdiagnostic
approaches that target core psychological processes that underlie multiple mental health and substance-
related problems. One transdiagnostic mechanism that is particularly relevant to alcohol and other substance
use is experiential avoidance (EA)— i.e., repeated, and maladaptive, use of substances and/or other behaviors
to escape or avoid unwanted thoughts, feelings, and/or urges. Acceptance and commitment therapy (ACT) is a
promising transdiagnostic intervention for PWH that targets EA. ACT is an empirically supported treatment for
multiple psychological and behavioral health-related outcomes; however there have not been any full-scale
RCTs of ACT for alcohol use among any population, including PWH. We recently adapted a telephone-
delivered ACT intervention originally developed for smoking cessation, into an intervention for PWH who drink
at hazardous levels (NIH/NIAAA; R34AA026246). With a multidisciplinary team, and with two rounds of input
from PWH, we developed a six-session, telephone-delivered ACT intervention for alcohol use and
subsequently conducted a pilot feasibility/acceptability RCT. We found high acceptability of the adapted ACT
intervention, and evidence of feasibility for conducting a full-scale, remote, RCT. The overall objective of this
application is therefore to determine the relative efficacy of ACT, compared to a standard Brief Alcohol
Intervention (BI), for reducing alcohol use and comorbid symptoms of depression, anxiety, and stress among
adult PWH who are hazardous drinkers. The specific aims are: To determine the relative efficacy of ACT,
compared to BI, for reducing alcohol use among PWH (Aim 1) and to determine if ACT has an effect on
transdiagnostic processes that in turn affect alcohol use and other psychological and functional outcomes (Aim
2). We will accomplish these aims by: conducting a fully remote, relative efficacy RCT in which we randomly
assign 300 PWH who are hazardous drinkers to either the ACT intervention we developed (n = 150), or a BI
intervention (n = 150) previously shown to reduce alcohol use among PWH. We will assess alcohol-related
outcomes—via self-report and a biomarker (phosphatidylethanol) – at baseline, post-treatment, and again 3-,
6-, and 12-months post-randomization. We will also measure EA to determine if it mediates treatment effects
for alcohol use and other psychological (i.e., symptoms of depression, anxiety, and stress) and functional
outcomes, measured at all timepoints.

Public health relevance
Project Narrative Alcohol is a significant problem in HIV care; novel intervention strategies are needed to decrease alcohol use and improve co-morbid psychological symptoms among people with HIV (PWH). The goal of this application is to conduct a remote, randomized clinical trial (RCT) of a brief, telephone-delivered Acceptance and Commitment Therapy (ACT) intervention to determine its efficacy relative to a standard brief alcohol intervention (BI). If successful, this intervention will have broad implications for implementation in HIV and other integrated care settings.